Administrative Supplement to UTMB Women's Health Research Scholars Program

PROJECT SUMMARY/ABSTRACT
This application is for an administrative supplement to UTMB’s K12 program “Building Interdisciplinary Research
Careers in Women’s Health” (BIRCWH) award (K12HD052023), which was recently renewed in 2020 for a 4th
cycle (2020-2025). The administrative supplement will provide funding for a fourth trainee position, to be filled
by a scientist or clinician from an underrepresented minority background. The goal of the UTMB BIRCWH
program, currently in its 18th year, is to launch junior faculty scholars into successful careers as independent
researchers in women’s health. The program has been continuously led by Dr. Abbey Berenson since its
inception and is supported by three Associate Directors who work with her to ensure robust leadership and an
interdisciplinary focus for all program activities. UTMB’s BIRCWH program is also supported by Resource Lab
Director Brandie Taylor, PhD, who provides support on study design and methodology. BIRCWH Scholars at
UTMB are guided by at least 2 of 20 Mentors, who work in 4 inter-professional teams built from existing
collaborations in areas of strength on campus: Reproductive Health, Aging, Infectious Diseases, and Health
Disparities/Hispanic Health. All Mentors have extensive publication records in women’s health, external funding
as PI (average of $1.37 million per year) and strong mentoring histories. Once appointed, Scholars make
Individual Development Plans and tailor their didactic experiences accordingly. All must demonstrate
competence in 10 educational objectives that define the fundamental knowledge, skills, and attitudes of an
accomplished investigator. Program activities include significant mentoring time, specialized seminars, individual
instruction in writing, and career development interactions with senior campus leaders. To prepare Scholars for
advanced academic roles, recent additions to the curriculum have included a journal club on SABV and a
requirement for Scholars to mentor biomedical students. An external review of Scholars, Directors, Mentors,
Resource Lab, and program processes occurs annually. Scholars must submit evidence of national
presentations, published manuscripts, and progress toward independent funding. The Advisory Committee
reviews all evaluation data and confirms each Scholar’s continuation in the program. BIRCWH leadership has
selected Gabriela Halder, MD to fill the fourth position supported by this administrative supplement. Dr. Halder
is a Panama-born urogynecological surgeon specialist with a clear passion for research and commitment to
increasing Hispanic representation in academia. She currently conducts research on pelvic floor disorders
among older women with low health literacy. The BIRCWH program will importantly provide Dr. Halder with a
unique opportunity to obtain the necessary skills to prepare competitive grant applications and establish
independence. As the fourth BIRCWH Scholar supported by this supplement, she will work on developing novel
methodologies to improve surgical preparedness among older women and will participate in a highly
personalized training plan comprising of the core BRICWH curriculum and targeted extracurricular didactics.

Public health relevance
PROJECT NARRATIVE This application is for an administrative supplement to UTMB’s K12 career training program Building Interdisciplinary Research Careers in Women’s Health (BIRCWH), which provides protected research time, structured mentoring, and career development opportunities to faculty conducting research on women’s health and/or sex as a biological variable. The administrative supplement will provide an additional fourth trainee slot to the program, to be filled by a scientist or clinician from an underrepresented minority group. Gabriela Halder, MD, a Hispanic urogynecologist who has born in Panama, has been selected as UTMB’s fourth scholar and she will conduct research on improving surgical preparedness among older women with low health literacy.